Shared Resource: Integrated Microscopy

CORE: Integrated Microscopy Shared Resource (Cell and in vivo Biology Group) PROJECT SUMMARY The Integrated Microscopy Shared Resource (IM SR) provides state-of-the-art-instrumentation, expert consultation, training, and software tools necessary to support cutting-edge cell imaging based research for investigators of the Dan L. Duncan Cancer Center. The instrumentation includes standard brightfield and widefield microscopy, deconvolution and confocal microscopes, high throughput microscopy coupled with automated robotics, and transmission electron microscopy (TEM) with full service processing and sectioning of cells and tissue samples. Plans for near term expansion of technologies and capabilities include scanning electron microscopy (SEM) and super resolution microscopy. The IM SR provides extensive training to DLDCC faculty and their research members to use instrumentation as an unassisted core service. IM SR staff assisted services are also provided to acquire images of user provided samples. An important aspect of both technician assisted and unassisted services is extensive consultation including experimental design, data interpretation, quality control, troubleshooting and assistance and training with commercial and in-house software tools for image analysis. We are also committed to educate cancer center researchers in basic imaging techniques and cutting-edge instruments by way of seminars, hands on workshops, microscopy classes, vendor demonstrations and one-on-one training in immunofluorescence and RNA in situ hybridization using next generation probes. Integrated Microscopy has been a Shared Resource of the DLDCC since its inception in 2006. Since the last renewal of the CCSG, the IM SR has supported the work of ~50 cancer center members annually resulting in ~20 peer-reviewed publications per year. We propose to continue to provide these essential and cutting-edge technologies for the cell imaging research needs of the Cancer Center in the future.